NY-CHAMP Community Engagement & Policy Action Core

COMMUNITY ENGAGEMENT AND POLICY ACTION CORE: PROJECT SUMMARY
The NY-CHAMP Community Engagement and Policy Action Core (CEPA) will bring together an interdisciplinary,
multi-sector team in a shared leadership and governance model to direct our proposed center of excellence. We
convene for the first time four esteemed community multiple principal investigators (MPIs) - Black Women's
Blueprint (BWB), Northern Manhattan Perinatal Partnership (NMPP), Caribbean Women's Association (CWHA),
and The Bridge Directory, with a broader coalition of community organizations, hospitals, academic institutions,
and governmental agencies from across NYC and NYS deeply invested in maternal health. The broad goals of
our NY-CHAMP CEPA are to assure 1) local community needs, priorities, and assets are the very center of our
Research Center of Excellence, and 2) our scientific endeavors result in maximum impact as well as structural
and policy change in ways that fundamentally alter the drivers of health and health equity for birthing people in
NYS and NYS. To achieve these goals, CEPA will practice intentionality, reflexivity, humility, and trust-building
to lead four aims that serve as critical foundation and scaffolding for NY-CHAMP's community engagement
efforts. In Aim 1, we will provide a sustained platform for iterative community input and engagement across our
research center through the Community-Hospital-Academic Research Governance (CHARGE) Board. In Aim 2,
we will launch a novel community-led maternal health provider + birthing patient training program that prepares
hospital actors for anti-racism, cultural humility, implicit bias, and racial allyship care; and prepares birthing
patients for empowerment, self-advocacy, and activation. In Aim 3, we will conduct a locally-led, co-design
process in parallel urban and rural sites with two safety-net hospitals of the NYC Health + Hospitals network and
in two counties in upstate New York in partnership with the University of Rochester and NYS Department of
Health, to set the stage for scalability for our interventions, findings, and partnership model. In Aim 4, we will
facilitate community-engaged research dissemination, collaboration, and policy action for maternal health equity
in NYC and NYS, including a novel community-led research capacity building project for an innovative virtual
doula care delivery platform. These aims, and the NY-CHAMP goals they support, are perfectly aligned with the
NIH's IMPROVE and UNITE Initiatives to solve and resolve the maternal mortality and morbidity crisis and reduce
disparities for birthing people and families across NYC, NYS, and ultimately the nation.